Approaches to heterocyclic rich anti-microbial natural products

Abstract
Natural products continue to provide inspiration for the development of small molecules (new
chemical entities) for use in medicine. Nitrogen heterocycles are found in many FDA-approved
drugs and therefore are considered privileged structures. Thus, the investigation of natural
products containing nitrogen heterocycles appears to provide high synergy and a high likelihood
of discovering new and useful bioactive molecules. This proposal is divided into three aims,
each of which involves the construction and elaboration of nitrogen containing heterocycles.
Aim 1 is directed towards the total synthesis of ceratinadin B, a member of the bromotyrosine-
derived natural product family. Isolated through bioactivity-guided fractionation, this molecules
possess activity as an inhibitor of mycothiol S-conjugate amidase a part of the biosynthetic
pathway for the assembly of mycothiol. Inhibition of mycothiol biosynthetic enzymes may be
useful in anti-tubercular therapy. Ceratinadin B contains two distinct structural domains, a
relatively common chiral spiro isoxazoline and an unusual imidazolyl-quinolone fragment for
which no synthetic studies have been reported. A general solution for the asymmetric
construction of the spirocylic fragment is proposed based on a Wacker inspired Pd/Cu-co-
catalyzed dearomatizing spirocyclization reaction to assemble the spiro isoxazoline. It is
proposed to use de novo construction of the bis heterocycle through a novel variant of the
Gould-Jacobs reaction to assemble the 3-hydroxyquinolone and a classical Hantzsch-like
synthesis of the aminoimidazole. Preliminary studies suggest that this sequence of events is
feasible. Condensation of the two heterocyclic building blocks will afford ceratinadin B. The
synthetic natural product and advanced precursors will be evaluated as anti-tuberucular agents
in cellular assays (M. smegmatis/M. marinum) through collaborators. Aim 2 seeks to investigate
a recently discovered tandem reaction sequence that generates quite complex polycyclic
azacycles from readily available building blocks. The optimization, scope, and limitations of this
sequence as well of the evaluation of post-cyclization transformation. Potential application to the
total synthesis of “-izidine natura; products are outlined. Aim 3 focuses on the development of
an asymmetric total synthesis of terrazoanthines A-B which were recently isolated from an
Ecuadorian invertebrate. It is planned to employ a desymmetrizing α-fuctionalization of a 4-
substituted cyclohexanone to permit the asymmetric annulation of the guanidine moiety through
a Hantzsch azole synthesis.

Public health relevance
Narrative The search for more effective and safer drugs to address the ongoing challenge of relieving the impact of human disease is continuing endeavor. Nature has proven to be an excellent source of inspiration catalyzing the development of new pharmaceuticals by producing structurally distinct natural products that exhibit potentially useful biological properties. In this submission we describe the development of new synthetic methods that enable the total chemical synthesis of several natural molecules and closely related derivatives which may have applications in drug discovery.